GENETICS OF ENDOCYTIC TRAFFICKING IN THE DROSOPHILA EYE

Autophagy is an important cellular response to metabolic stress, challenges to
proteostasis and diverse other insults such as infections. These conditions induce the
formation of an isolation membrane that initiates the engulfment of unspecific
cytoplasmic content in the context of the starvation. In response to other stressors more
specific targets may be tagged for degradation such as aggregates of misfolded
proteins, dysfunctional mitochondria, or pathogens. The initial isolation membranes (also
called phagophores) grow and eventually engulf the cargo in double-membraned
autophagosomes. Their subsequent fusion with late endosomes and lysosomes will
deliver the autophagosomal content for degradation and recycling of nutrients to
stressed cells. Beyond its importance in the starvation response, basal autophagy is
increasingly recognized as an important quality control mechanism that reduces
degeneration of neurons and photoreceptor cells and has implications for cancer and
infectious diseases. Therefore, it is important to understand the distinct cellular signaling
pathways that adjust the rate of autophagy to a cell’s physiology. Careful calibration of
such signaling is essential as excessive autophagy is lethal to cells. We identified Acinus
as a regulator in the induction of basal, starvation-independent autophagy. The Acinus
protein integrates signals from multiple pathways to modulate the function of core
autophagy proteins. This grant aims to understand the molecular mechanisms that
regulate the levels of Acn protein and its activity. Aim 1 proposes to define the
phosphatases and kinases responsible for regulating its activity. Aim 2 will analyze the
mechanistic link between Acinus and the activation of Atg1, the master regulatory kinase
of the autophagy pathway.

Public health relevance
Project(Narrative( ! Autophagy is an important cell biological mechanism that cells use to restore energy supplies at time of starvation and to rid themselves of damaging content such as aggregated proteins during neurodegeneration, dysfunctional mitochondria or invading bacteria. The specific aims described in this proposal will explore the mechanism boosting starvation-independent autophagy to address cellular challenges without the damage that can result from excessive autophagy. Because autophagy is important for suppressing the early effects of neurodegeneration and has complicated and sometimes contradictory consequences in the context of different cancers, understanding these mechanisms is important for human health.!